Role of RNA-binding protein DDX3X in the endocardium during development and disease

PROJECT SUMMARY
Cardiac development is a complex process that occurs early during embryonic development and requires
precise regulation. Early cardiac development, especially of the endocardial and myocardial lineages, is
implicated in the development of congenital heart diseases (CHDs). Unfortunately, despite CHDs being the
most frequent birth defect affecting approximately one in 100 live births, very few mechanisms are understood
about many different forms of CHDs.
Proper cardiac development requires precise post-transcriptional regulation, such as alternative splicing,
translation initiation, and mRNA modification. These functions are mediated by RNA-binding proteins (RBPs),
and unsurprisingly, mutations to many RBPs are implicated in cardiac development and formation of CHDs.
One such RBP is DDX3X, which is known from clinical evidence to have implications in CHDs: patients with
mutations in DDX3X exhibit DDX3X syndrome, marked by neurodevelopmental disorders and increased risk of
CHDs. However, DDX3X has not been well-studied to date in the context of heart development. My proposed
research will study the dosage-sensitive effects and mechanisms of DDX3X in the endocardial lineage during
cardiac development.
In Aim 1 of this proposal, I will determine the effects of reduced DDX3X levels on endocardium formation and
function. Using transgenic mice, I will conditionally delete DDX3X in male and female mouse endocardium.
Expression level of DDX3X in the endocardium will be quantified using immunofluorescent imaging and flow
cytometry. I will then characterize resulting phenotypes by examining phenotypic onset, structural and
functional consequences, and cellular and molecular consequences in the heart using a combination of
brightfield and immunofluorescent imaging, weight measurements, and echocardiograms.
In Aim 2 of this proposal, I will identify the molecular mechanisms of DDX3X in the endocardium. Using
immunofluorescent imaging, I will characterize the subcellular localization of DDX3X in the endocardium. I will
then identify the direct regulatory network of DDX3X in the endocardial lineage using RNA-seq and Ribo-seq.
Targets will be validated against pre-existing eCLIP data as well as in an in vitro system of human pluripotent
stem cell-derived endocardial cells.
The results of this research will contribute to our understanding about RNA biology, gene dosage, development
and disease.

Public health relevance
PROJECT NARRATIVE Embryonic heart development is a complex process that occurs early during development and requires fine regulation at the post-transcriptional level through the action of RNA-binding proteins. One such RNA-binding protein is DDX3X, which is known to cause neurodevelopmental disorders and increased risk of congenital heart defects when mutated in patients. This research will examine the role and mechanism of DDX3X in the endocardium, a critical cell type during cardiac development, to further our understanding of the role of DDX3X during cardiac development and disease.